CDKN1A (p21) regulation of cyst growth

Mutations disrupting cilia function (Pkd1 or Pkd2) cause renal cyst formation. The relationship between cilia, the Pkd proteins (polycystins) and cytogenesis is poorly understood. Induction of Pkd1 and Pkd2 gene loss in adult mice causes focal cyst initiation, despite the genes being efficiently deleted from nearly all the cells in the kidney. It was proposed that an additional insult may be required for cystogenesis to occur. Multiple groups have now reported that the number of cysts and the cyst expansion rate is accelerated by renal injury. This led to the hypothesis that polycystins regulate an injury and repair process. In the absence of polycystins, cells that experience an injury are unable to repair adequately leading to maladaptive repair conditions. We predict these maladaptive-repair cells contribute to the focal cysts in adult mutants and to the rapidly forming, widespread cysts induced by injury. This is further supported by gene expression analyses revealing that a subpopulation of epithelial cells in pre-cystic mutants have elevated expression of genes induced by renal injury. One gene we found to be aberrantly expressed prior to cyst initiation in the Pkd1 and Pkd2 mutants and following injury is CDKN1A (p21), a protein involved in cell cycle inhibition and maintenance of epithelia cell differentiation. In normal kidney epithelia, p21 is not readily detectable, but is induced rapidly by injury to prevent injured cells from proliferating until repair is complete. p21 down regulation then allows the cell to progress through the cell cycle to complete tissue repair. Unexpectedly, the number of p21 expressing cells was greatly increased in Pkd2 mutants , despite cystic kidney disease being considered a proliferative disorder. Our data are in direct contrast to findings from nearly 20 years ago showing that Pkd1 and Pkd2 function through the Jak/Stat pathway to induce p21 expression. One goal of this project is to directly address this controversy by defining the relationship between p21 expression and cyst development and severity in Pkd1 and Pkd2 mutants. We will determine whether is abnormally regulated as part of an altered injury response in the mutants. Our studies will determine whether cells expressing p21 display cellular characteristics and transcriptional changes linked to cyst development. We will trace the fate of cells that express or had expressed p21 to determine if they contribute to cysts. Finally, using innovative mouse models where we can sustain or repress p21 expression at defined stages of cystogenesis, we will directly test the importance of p21 in cyst initiation and expansion. Collectively, our data will provide a detailed understanding of p21’s role in cystic disease. As such, the data will pave the way for innovative strategies to manage PKD more effectively, potentially leading to improved treatment options and better outcomes for PKD patients.

Public health relevance
PROJECT NARRATIVE: Mutations in proteins required for cilia assembly (Ift88) and function (Pkd1 and Pkd2) cause kidney cysts that are associated with prolonged expression of injury-induced genes prior to cyst initiation. Our data indicate that one of these early response genes potentially involved in the cystic phenotype is the cell cycle kinase inhibitor CDKN1A (p21). This project will utilize the Pkd1, Pkd2, and Ift88 cystic kidney disease mouse models to assess the relationship between p21 expressing cells and cyst severity, to evaluate p21’s role in the altered injury response known to accelerate cyst formation, to test p21’s impact on cellular phenotypes and transcriptional networks associated with cyst formation, and to determine whether p21 is a critical regulator of cyst initiation and expansion, with the ultimate goal of informing on new strategies to inhibit or slow cyst growth in PKD.